GPR123 Activation by Steroid Ligands

Project Summary
Steroid hormones mediate crucially important aspects of development, metabolism, inflammation,
immune function, and behavior. Many effects of steroids are due to activation of their classical nuclear receptors
to control transcription, but steroids can also control numerous cellular processes via rapid stimulation of G
protein signaling. For most steroids, though, the receptors mediating these rapid non-genomic actions have not
yet been identified. In preliminary studies, the adhesion G protein-coupled receptor GPR123 (also known as
ADGRA1), which is highly expressed in the brain and known to regulate metabolism, was screened for potential
stimulation by steroids and several hits were identified. We propose to build on these screens and
pharmacologically characterize steroid binding by GPR123, including assessment of signaling bias by steroid
ligands through both G protein- and arrestin-mediated signaling pathways. We also propose to elucidate the
structural determinants of steroid activation of GPR123. These studies will provide new insights into the rapid
non-genomic actions of steroid hormones and furthermore lay the groundwork for the development of GPR123-
targeted therapeutics that might be useful in the treatment of metabolic disorders and other human diseases.

Public health relevance
Project Narrative The actions of steroid hormones on development, metabolism, inflammation, immune function, and behavior have been studied for decades but are still incompletely understood. We have screened a brain- expressed receptor called GPR123, which previously did not have any known ligands, and identified several steroids as novel ligands for this receptor. In this project, we will elucidate the fundamental pharmacology of GPR123 and determine how it binds to steroids, with the eventual goal of using this information to develop therapeutics capable of targeting GPR123 for the treatment of human disease.